Examining the role of defective oxidative phosphorylation in the normal and diseased prostate

ABSTRACT
Lower urinary tract symptoms (LUTS) are a significant burden to aging men and are often as a result of benign
prostatic hyperplasia (BPH). While BPH/LUTS is not commonly fatal with proper medical intervention, it does
cause a significant reduction in quality of life for many men as they age. Furthermore, BPH/LUTS increases risk
of mortality and results in billions of dollars in healthcare costs annually. There is currently a subset of BPH/LUTS
patients that fail FDA-approved treatments (α-blockers, 5ARI), and these patients have been shown to have
increased prostatic fibrosis. There is no FDA-approved medication targeting fibrosis or the aging process in
BPH/LUTS, even though aging is the greatest risk factor. This proposal aims to develop a better understanding
about the role of aging, fibrosis, and mitochondrial dysfunction in BPH/LUTS. Mitochondrial dysfunction is a
hallmark of both aging and fibrosis and has not been thoroughly studied in relation to BPH/LUTS. Preliminary
data suggests that oxidative phosphorylation (OXPHOS) is a mitochondrial pathway contributing to cellular
dysfunction in BPH/LUTS. Aim 1 of this proposal intends to investigate the connection between OXPHOS
disruption and lower urinary tract dysfunction (LUTD) in a novel mouse model. Aim 2 of this proposal will
investigate the connection between OXPHOS disruption and pathways associated with fibrosis, using genetic
loss-of-function cell line models. Finally, Aim 3 will work to identify a new pathway of interest for treatment, using
oleic acid as a mitochondrial metabolism modulator. Collectively, these aims will improve our overall
understanding of the processes underlying BPH/LUTS, with a special focus on aging, mitochondrial dysfunction,
and fibrosis. This proposal hopes to provide translational outcomes that can eventually improve patient care and
treatment options.

Public health relevance
PROJECT NARRATIVE This proposal will determine the contribution of defects in oxidative phosphorylation to the development of fibrosis in benign prostatic hyperplasia (BPH). Specifically, this project aims to investigate the mitochondrial changes associated with aging to develop a better understanding of how oxidative phosphorylation is driving disease. This work will provide new avenues for biomarker development and treatment targets.